Adhesin Amyloid Biology

Heterotypic interactions between amyloid proteins are critical in understanding the outcomes of amyloid-based
infection and treatment; however, the molecular and structural determinants that allow or limit amyloid cross-
seeding have been difficult to define. Towards this goal, it will be informative to identify amyloid interactions on
a larger scale, generating a knowledgebase that can contribute to the identification of rules governing cross-
seeding among amyloids. The adhesins are an important family of functional amyloids central to fungal biology
and virulence. Adhesins are cell wall-attached proteins that mediate cell-cell adhesion in fungal filamentous
growth and biofilm formation. Notably, nearly 90% of adhesins are predicted functional amyloids, and many
have been demonstrated to possess core sequences capable of forming amyloid fibrils in solution. In the
yeasts S. cerevisiae and C. albicans, adhesins aggregate to form cell surface nanodomain patches important
in the enhanced cell-cell adhesion of pseudohyphal and hyphal filaments. The ability to transition between
yeast-like and filamentous growth forms is required for virulence in the opportunistic human fungal pathogen C.
albicans, and adhesins have been identified as virulence factors. Adhesin sequences with strong
amyloidogenic potential are required for wild-type cell-cell adhesion and filamentation. Fungi preferentially bind
to like cells in biofilms and filamentous communities. Since this binding is mediated through adhesins, we
hypothesize that specificity in amyloid interactions underlies kin discrimination and cellular self-recognition in
yeast. Our preliminary data are consistent with this hypothesis, identifying important sequence variation in
amyloidogenic regions of the well-studied adhesin Flo11p between filamentous and non-filamentous strains of
S. cerevisiae. We also identify that single amino acid changes in amyloid proteins can strongly affect cross-
seeding specificity. Here, we propose to test adhesin protein isoforms of Flo11p from filamentous and non-
filamentous strains of S. cerevisiae for cross-seeding. Species barriers to adhesin interactions will be tested
using the set of identified adhesins from S. cerevisiae and C. albicans. The adhesins present an informative
platform for the investigation of amyloid interaction specificity, and a genome-wide set of yeast functional
amyloids will be tested for amyloidogenic potential and heterotypic interactions using the adhesin framework as
a novel screening scaffold. Collectively, this work will determine the specificity and barriers that constrain
heterotypic adhesin interactions in yeast, while offering broader insight into the rules of amyloid cross-seeding.
Using the adhesins as a scaffold for yeast surface display, we present a method amenable to high throughput
applications for the identification of new amyloids and the rapid assessment of specific aggregation barriers.
Adhesins are fungal-specific virulence determinants relevant as targets for new antifungal treatments.

Public health relevance
Fungal cells have a family of surface-attached proteins that aggregate to enable cell-cell interactions and virulence through properties shared with disease-causing proteins that aggregate in neurodegenerative disorders. We hypothesize that the specificity of fungal interactions through these aggregation-prone sequences drives cell-cell recognition in microbial communities, and here we will determine cross-protein interactions with these sequences. The data will identify barriers to this type of protein aggregation and advance our understanding of targets for antifungal drug development.